Transcriptional Activator Complex of the Mammalian Circadian Clock

Project Summary
Circadian clocks are endogenous ~24-hour oscillators that drive daily rhythms of
biological processes. In mammals, circadian clocks are found in the brain and in most
peripheral tissues. Together, the distributed clocks constitute the basic timing system that
regulates physiology, metabolism, and behavior.
The mammalian circadian clock is built on a transcriptional negative feedback loop that
generates circadian rhythms at the molecular level. The transcription factor CLOCK-BMAL1
is at the heart of this feedback loop, acting as the core positive driver of circadian clock
transcription. CLOCK-BMAL1 has been assumed to act in vivo as a heterodimer, but we
have shown that in nuclear extracts from mammalian tissues it is exclusively embedded in an
~800-kDa protein complex during the transcriptional activation phase of the circadian cycle,
far larger than the ~170-kDa heterodimer. Our preliminary biochemical, mass spectrometry,
and single-particle electron microscopy results together unexpectedly suggest that this
complex consists entirely or mostly of multiple CLOCK-BMAL1 heterodimers assembled into
an oligomeric structure.
These observations tell us that the full molecular nature and functional properties of
the circadian clock transcriptional activator remain to be discovered, a fundamental gap in our
understanding. The goal of this application is to analyze the composition, function, and three-
dimensional structure of the enigmatic ~800-kDa CLOCK-BMAL1 complex. If successful, the
project offers to extend and deepen our knowledge of circadian clock transcription, possibly
to an atomic level of resolution.
Advances in understanding the circadian clock will have important implications for our
knowledge of the regulation of behavior and physiology, as well as for human health and
disease. Circadian clock defects result in broad physiological dysfunction, producing
disrupted sleep-wake cycles, metabolic syndrome, and increased cancer incidence. There
are also links between clock dysfunction and mood disorders, including bipolar disorder. The
proposed investigation aims to provide insights into the molecular machinery of the biological
timing system essential for health.

Public health relevance
Project Narrative Relevance to human health Sleep disorders, obesity, diabetes, and mood disorders are global health hazards, and in recent years there has been a growing realization that these conditions are all linked. The goal of the proposed investigations is to provide new insights into the circadian clock, a biological timekeeping system that controls the sleep-wake cycle, feeding behavior, and metabolism. Deeper understanding of the circadian system could ultimately lead to improved diagnosis and treatment of sleep disorders, obesity, diabetes, and bipolar disorder.